Mass Spectrometry in Systems Biology

[unreadable] DESCRIPTION (provided by applicant): Systems biology represents integration of measurements of genomics, gene transcription, proteomics and metabonomics. The completion of a genome sequence for an organism provides the basis set of proteins and enzymes that are present in the organism. In multi-cellular organisms each cell type uses a portion of the set of genes to perform specialized functions. Cells must respond to changes in the environment and the molecules of the cell must do so as part of a system and the cell must respond as part of the organism or physiology. Integral to understanding biological systems is the ability to discover and measure changes in the system. Mass spectrometry is a key technology for the measurement of molecular structure and molecular abundance. Mass spectrometry is being applied to the measurement of DNA, RNA, protein and small molecule metabolites. The Keystone meeting would present the latest developments in the methods and applications of mass spectrometry for the analysis of DNA, RNA, Proteins and naturally occurring metabolites. Topics emphasizing global measurements as well as highly specific and accurate molecular measurements will be presented. [unreadable] [unreadable]